Precision medicine approaches to renal osteodystrophy

PROJECT SUMMARY/ABSTRACT
Renal osteodystrophy (ROD) is a complex disorder of cortical bone quality and strength. Impaired cortical bone
is due to the combined actions of elevated parathyroid hormone (PTH) levels and changes in bone hormones
as a result of kidney failure. ROD affects nearly all patients with chronic kidney disease (CKD) and results in
cortical bone loss, cortical-type fractures and cardiovascular events. The current goal of ROD treatment, to re-
duce high bone turnover due to renal hyperparathyroidism, is contraindicated in the presence of low turnover yet
reliable ways to determine low turnover status are lacking. The Kidney Disease Improving Global Outcomes
(KDIGO) guidelines recommend that treatment is guided by the biomarkers PTH and bone specific alkaline
phosphatase (BSAP) and not to treat when turnover is low. However, despite these recommendations, cortical-
type fracture incidence has doubled in dialysis patients over the past 25-years, a failure in fracture reduction due
in part to PTH and BSAP being developed to identify turnover in trabecular rather than cortical bone. Further-
more, although KDIGO recommends tetracycline-labeled bone biopsy to define turnover and guide treatment,
the histomorphometry is also based on analysis of trabecular and not cortical bone, the latter being the primary
site of PTH action. Our published preliminary data suggest that trabecular turnover is a poor surrogate for cortical
turnover, with only moderate correlations between bone compartments (R2 59%). Thus, there is an unmet need
to identify biomarkers with high diagnostic accuracy and clinical utility for the identification of low cortical turnover,
used without or without trabecular turnover, to guide treatment decisions and for use in clinical trials. In our
published data, we hypothesized that an a priori defined subset of microRNAs (miRNA) that regulate osteoblast
(miRNA-30c, 30b, 125b) and osteoclast (miRNA-155) development would be accurate biomarkers of low cortical
turnover. In 23 CKD patients with bone biopsies, the areas under the curve for discrimination of low from non-
low turnover were 0.866, 0.813, 0.813, and 0.723 for miRNAs-30b, 30c, 125b and 155 respectively, 0.925 for a
panel of the 4 four miRNAs combined, while PTH and BSAP, individually and together, did not discriminate in
this population. Based on these findings, our central hypothesis is that circulating miRNAs discriminate ROD
cortical bone subtype. In a cohort of 90 CKD patients with low, normal, and high turnover (30/group; Aim 1) we
will use miRNAseq to identify novel miRNAs that correlate with ROD type and determine if their combination with
the preliminary panel enhances discrimination. In 40 ROD patients managed with strategies that change turnover
from high to low or low to high (n=20/group; Aim 2), we will determine if changes in histology-based turnover are
reflected by changes in the optimized panel and if the circulating miRNA panel mirrors bone-tissue miRNA ex-
pression. Then, we will determine if the panel is related to bone quality and strength (Aim 3). Our results will
determine if the circulating panel can serve as a biomarker for guiding ROD management. This high impact
proposal has the potential to result in a paradigm shift in the non-invasive diagnosis and management of ROD.

Public health relevance
PROJECT NARRATIVE Treatment of renal osteodystrophy is impeded by the lack of practical and accurate tools to determine underlying bone turnover. Gold standard bone biopsy is not practical in the clinic for the vast majority of kidney disease patients and parathyroid hormone and bone alkaline phosphatase have insufficient accuracy for turnover type to safely and confidently guide treatment of renal osteodystrophy. In the present investigation, we will study a microRNA approach as a novel non-invasive biomarker of turnover for renal osteodystrophy.